TIME PROCESSING IN STIMULANT USERS: IMPULSIVITY AND TEMPORAL DISCOUNTING

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. 1. To determine the role of the subjective sense of time in decision making 2. To evaluate the association between impulsive decision making and time perception